Enteroendocrine Regulation of Intestinal Metabolism

PROJECT SUMMARY
Dr. Heather McCauley is mentored by Dr. James Wells at Cincinnati Children’s Hospital Medical
Center (CCHMC), the largest pediatric research institution in the nation. CCHMC ranked 2nd in NIH support in
2017 and is home to an NIDDK-sponsored Digestive Diseases Research Center with a vibrant community of
physicians and scientists. CCHMC provides a very supportive training environment for young investigators. Dr.
McCauley proposes an innovative cross-disciplinary research plan which bridges developmental biology, stem
cell and organoid medicine, gastroenterology and nutrition, endocrinology, and metabolism.
Enteroendocrine cells (EECs) are specialized intestinal epithelial cells which secrete more than 20
bioactive peptides to regulate satiety, gut motility, glucose homeostasis, nutrient absorption, and whole-body
metabolism in response to ingested nutrients. While the systemic targets of EEC hormones are well known,
such as the brain and the pancreas, the role of EEC peptides in regulating the function of the intestine itself is
surprisingly understudied. Our lab has developed a unique, high-throughput human model system to test the
roles of individual EEC peptides on intestinal function by generating EEC-deficient human intestinal organoids
from pluripotent stem cells. We recently used this model system to show that some EECs regulate ion-coupled
nutrient absorption in neighboring cells. Because EECs are nutrient-sensing cells, we considered that they
might coordinate other intestinal responses to nutrient availability. Most EEC peptides signal via G-protein
coupled receptors which activate second messengers to modulate the function of their target cell. These
second messengers are intimately linked to ancient regulators of cellular metabolism, such as mammalian
target of rapamycin (mTOR), which are known to play essential roles in many intestinal functions. This
proposal will test the hypothesis that EECs regulate cellular metabolism in the stem cell niche (Aim 1) and in
the differentiated enterocyte (Aim 2), thus impacting both intestinal homeostasis and efficiency of nutrient
absorption. As EECs are now common targets for the treatment of type 2 diabetes, understanding how EECs
affect intestinal metabolism and function will inform how dietary or pharmacological manipulation of EECs will
impact gut health, nutrient absorption, and whole-body metabolism.
To ensure success of the proposed research strategy, Dr. McCauley requires additional mentored time
to become fluent in metabolic and metabolomic assays. Dr. McCauley has obtained a co-mentor, Dr. Kenneth
Setchell, an international expert in using Mass Spectrometry to understand nutrition- and digestive disease-
related changes in metabolism. Dr. McCauley proposes a rigorous yet feasible schedule of formal and informal
training opportunities in metabolomics. At the conclusion of the mentored portion of her training, Dr. McCauley
will be established as a fully independent, leading young investigator in the field of gastrointestinal metabolism,
a critically understudied niche in the GI community.

Public health relevance
PROJECT NARRATIVE The goal of this project is to identify how the nutrient-sensing cell of the intestine, the enteroendocrine cell, may signal changes in nutrient availability to other cells within the gut. This has significant implications for how changes in dietary intake or pharmacological manipulation of enteroendocrine peptides may influence the capacity for regeneration, nutrient absorption, and overall metabolic health. With the staggering rates of metabolic and digestive disease in the United States, understanding how enteroendocrine cells regulate gut function is a pressing public health concern.